SIDEROPHORE ANALOGS IN RADIOIMMUNODETECTION OF TUMORS

Our aim is to develop novel antibody conjugates for use in the radioimmuno-detection of tumors. In response to the problems associated with antibody-DTPA-radiometal imaging methodologies with regard to liver deposition of the metal, a number of more specific chelators will be investigated. Based on the capability to tightly bind the metal, and because of their greater lipophilic character and lack of excess functionality, enhancement of membrane transport of the ligand-metal complex is to be expected. The overall synthetic strategy will allow a large number of alternatives to be considered in the future, while the compounds close correlation with the ubiquitous natural products would not indicate any future cytotoxic problems. Antibody conjugation will follow protocols established in these laboratories and elsewhere. Successful completion of Phase I followed by fulfillment of the compounds potential in the Phase II in vivo studies; will lead to a new generation of tumor imaging agents.